Imaging Strategies to Evaluate Bone Health After Nerve Injury Repair and Rehabilitation

Peripheral nerve damage is a debilitating consequence of traumatic or iatrogenic injury to the extremities of
soldiers, and a secondary outcome following spinal cord injury (SCI). Functional recovery from nerve damage is
often poor, especially for chronically injured nerves, resulting in impaired motor function, sensory loss, and pain.
Beyond the direct impacts of nerve injury, systemic effects related to nerve damage are additionally devastating.
One particularly insidious and unsolved clinical challenge resulting from nerve injury is a reduction in the
structural integrity and strength of bone. This is in part due to reduced bone loading due to motor dysfunction.
However, increasing evidence highlights strong coupling among bone innervation (sensory and sympathetic),
vascularity, and regulation of bone turnover. Beyond increased risk of fracture, bone degeneration can also
impact whole-body homeostasis, including hematopoiesis and downstream immune dysfunction. Given such
long-term sequelae of chronic nerve injury, Veterans bear a tremendous burden on their quality of life, and the
VA healthcare system bears a corresponding financial challenge.
Imaging is an important strategy for evaluating bone health after nerve injury, nerve repair, and rehabilitative
intervention. Unfortunately, existing techniques are limited. Dual energy X-ray absorptiometry (DEXA), which
quantifies bone mineral density (BMD), is considered the standard of care in clinical practice. However, the
majority of bone components, including the organic matrix and water, which together occupy approximately 60%
of bone by volume, is inaccessible using current approaches. These “invisible” tissue components make
important contributions to the mechanical properties of bone, partially explaining why BMD alone poorly predicts
fractures or other bone-related complications. Further, there is no opportunity to non-invasively measure
biological correlates of bone health such as vascularity. These shortcomings contribute strongly to the lack of
current interventional approaches to preserve or restore bone health.
In this study, we propose to apply innovative magnetic resonance imaging (MRI) to interrogate several
structural and physiological properties of bone following nerve injury and rehabilitative intervention. In particular,
we will develop and apply quantitative ultrashort echo time (UTE) MRI techniques to measure multi-scale
features of bone, including macro- and micro-scale structure and micro-scale vascularity. Our specific aims are:
1) To evaluate changes in bone morphology and neurovascular supply during the progression of chronic nerve
injury; 2) To evaluate changes in bone morphology and neurovascular supply following repair of acute and
chronic nerve injury; 3) To evaluate changes in bone morphology and neurovascular supply following treadmill-
based rehabilitation following chronic nerve injury and repair.
The primary outcome of our proposed study is to validate the utility of novel imaging approaches in measuring
key aspects of bone structure and bone health following nerve injury, repair, and rehabilitation. A secondary
outcome of this study is to better understand neurovascular and muscular biological changes that underlie bone
degeneration and imaging outcomes, thus providing a more mechanistic rationale for additional therapeutic or
rehabilitative intervention. Towards improved bone health following nerve injury, our ultimate goal is to identify
MRI biomarkers that may then be deployed clinically, to non-invasively evaluate the effectiveness of rehabilitative
strategies on bone composition and strength following severe nerve injury.

Public health relevance
Peripheral nerve damage is a debilitating consequence of injury to the extremities of soldiers, long term consequences of which significantly impact Veterans, their caregivers, and the Veteran Healthcare System. In addition to loss of sensory and motor function, a particularly insidious and unsolved long-term consequence associated with nerve injury is a reduction in the structural integrity and strength of bone; this can increase risk of fracture as well as impact whole-body homeostasis. In this proposal, towards improved preservation and restoration of bone health following nerve injury, we propose to apply innovative magnetic resonance imaging (MRI) approaches to examine several structural and physiological properties of bone following nerve injury, nerve repair, and rehabilitative intervention.